California Milk and Dairy Food Safety Manufactured Food Regulatory Program Standards Maintenance and IT Development

Abstract
The primary goal of this project is to further develop, implement, and sustain MDFSB's
best practices for a high-quality regulatory program to enhance food safety. This would
entail the strengthening of interagency collaboration, cooperation, communication, and
sustainment of conformance with the Manufactured Food Regulatory Program Standards
(MFRPS). Grant funds will be used to enhance current dairy inspection program
capabilities and provide the necessary infrastructure to continue further development and
sustainment of MFRPS. MDFS also proposes a special project to update its Emerging
Threats Database (ET) to manage daily business activities such as licensing, registration,
certification, permitting, inspection, traceability, compliance, and enforcement.

Public health relevance
Narrative The Milk and Dairy Food Safety Branch (MDFSB) of the California Department of Food and Agriculture (CDFA) is charged with the mission and responsibility of ensuring that California's milk, milk products, and products resembling milk products are safe and wholesome, meet microbial and compositional requirements and are properly labeled. To fulfill this mission, MDFSB conducts regulatory food safety activities at all sectors of the dairy industry from farm to table, including inspections of dairy farms, bulk milk tanker trucks, milk processing plants, industry milk testing laboratories and manufacturers of single-use dairy containers. MDFSB also collects regulatory samples of milk, milk products and water supplies for laboratory testing, responds to consumer complaints and food safety incidents, and initiates impounds and product recalls to protect public health as warranted. In addition, sanitation ratings by MDFSB personnel certify milk supplies and milk plants for U.S. Food and Drug Administration (FDA) approval to ship Grade-A milk and milk products in interstate commerce. MDFSB as part of the AHFSS Division of CDFA, relies on the ET database to manage daily business activities such as licensing, registration, certification, permitting, inspection, traceability, compliance, and enforcement. ET is also integrated with the California Animal Health and Food Safety (CAHFS) Laboratory System to electronically submit and receive testing results for dairy samples. A 2016 analysis of ET, performed by the California Department of Technology (CDT) Data Management Consultant, found that ET's current data model no longer represents the business need of AHFSS. The report also identified that the means to ensure reliable shared data, necessary for key management decisions, are not fully implemented, resulting in duplicate information and orphaned records (not linked to a parent record). The following data quality issues are just a few of the concerns identified in the CDT report: duplicate farm records (over 3,000); incomplete data (59,380 active operation records with no date); and invalid data issues (street number, street name, and street suffix are all in the same field and are not uniform, making it hard to search for existing premises). Since this report, these numbers have increased with the adoption of mobile devices to capture activity. Accurate information is essential to a rapid and effective response during an animal health or food safety incident and any delay increases the potentially negative effects and hinders control measures. The ET 2 database will help CDFA, including the Milk and Dairy Food Safety Branch, to respond efficiently and effectively to future food safety incidents, disease outbreaks, and natural disasters. This project is in accordance with the purpose of special projects outlined in the RFA to develop and implement special projects that support innovation and integration in a nationally Integrated Food Safety System (IFSS) using the MFRPS framework. This track will also support other emerging food safety priorities that develop over the lifespan of the project. CDFA is responsible for supporting the responsible jurisdiction and coordinating activities during and immediately following a disaster impacting the agriculture and food industry and supporting the recovery of impacted industries and resources post disaster. The plan specifically references AHFSS as a resource to protect public health, the health of California's livestock and poultry, and to provide safety of food at animal origin. This would include manufactured dairy products.